Characterizing and modulating motor cortical dynamics underlying rapid sequence learning in primates

PROJECT SUMMARY
A fundamentally important question is how the nervous system converges on optimal solutions during the
process of motor learning. A growing body of evidence in humans has remarkably demonstrated the presence
of micro-offline gains (MOGs), or significant “offline” performance gains after a brief rest period (~10 second),
during motor sequence learning, which diminish as a fast and reliable performance is consolidated.
Magnetoencephalography (MEG) recordings have linked this rapid form of consolidation to 13-30 Hz oscillations
in field potentials (β, beta) and replay of broad-band field potential patterns across the motor cortex, particularly
the primary motor cortex (M1) – an area essential to the execution and learning of motor skills. However, it
remains unclear how high-resolution spiking signals in M1 are reflected in reactivations of spatially broad MEG
signals and how offline β may support consolidation. Moreover, it is unclear if such micro-offline processing is
causal to rapid behavioral modifications.
Here, we use a novel sequential reach task for non-human primates (NHPs) that reliably elicits MOGs, combined
with LFP and neuronal spiking recordings in motor cortex, to probe how the primate motor cortex enables rapid
sequence learning. Our preliminary data shows that task-active neuronal ensembles in M1 are reactivated during
short breaks, particularly in early learning when MOGs are highest. In contrast, offline β is highest during later
breaks and is inversely correlated with MOGs. Together, these results motivate our overall hypothesis that
micro-offline reactivation of task-active spiking patterns promotes rapid learning, and as behavior is
optimized, offline β increases to promote stability of learned neural activity patterns.
To test this hypothesis, we use an interdisciplinary approach of high-speed reach and gaze tracking, precise
neural recordings, computational modeling, and causal manipulations. In Aim 1, we will assess whether
reactivations of task-active ensembles during brief rest periods correlate with rapid behavioral modifications. In
Aim 2, we will quantify the relationship between offline β-coherent spiking patterns and changes in online spiking
dynamics. Finally, in Aim 3, we will use 20 Hz alternating current stimulation (ACS) to causally determine the
role of offline β in regulating rapid consolidation and behavioral stability. Together, these experiments will further
our understanding of how the primate cortex enables adaptive behavioral modifications on short timescales and
lay a strong foundation for stimulation-based interventions for pathological conditions of behavioral and cognitive
rigidity, such as Parkinson’s disease, obsessive-compulsive disorder, and depression.

Public health relevance
PROJECT NARRATIVE During motor learning, behavior progresses from a highly variable state where potential actions are explored, to a stable state where reliable action sequences are performed – a progression that is also reflected in the neuronal dynamics of primary motor cortex (M1). However, the precise neural mechanisms that that facilitate such consolidation in primates remain poorly understood, particularly on rapid timescales. Using an interdisciplinary approach of multimodal behavioral monitoring, precise neural recordings, computational modeling, and causal manipulations, the proposed research aims to characterize and manipulate the neural mechanisms that drive rapid behavioral convergence.